Time toxicity of cancer: the time demands of cancer-related activities and their impact on well-being and quality of life

Project Summary
Cancer care is becoming increasingly complex, with growing demands on patients’ energy and time. As a
result, patients often have to neglect their usual life activities and relationships. Such ‘time toxicities’ of cancer
are rarely acknowledged and play little role in care considerations. Further, no scoring systems exist to
measure the time burden of cancer care. Having to weigh potential survival benefits of treatments against
added time burdens especially affects those at risk of premature death. Therefore, there is a critical need to
measure and reduce the time toxicities of cancer. The overall objectives of the proposed research are to
describe and quantify sources of cancer-related time toxicity among individuals receiving treatment for cancer
and their effect on well-being, and to create time toxicity scores which can be used in future studies to identify
opportunities to minimize time toxicity. The general hypothesis is that combining sensor-based objective data
with subjective self-reported measures of time spent on healthcare-related activities will accurately measure
the time burden of cancer care and identify areas for interventions related to treatment delivery to reduce this
burden. This hypothesis will be tested via the following specific aims: (1) Measure and describe components of
objective time use associated with cancer-related healthcare interactions via a mobile health application; (2)
Characterize associations between measures of cancer-related time use and self-reported well-being, and
explore the role of context in modifying these associations; (3) Create a time toxicity summary score based on
measures of cancer-related time use and assess its association with psychosocial outcomes. We will conduct
a 28-day prospective cohort study of 80 individuals with advanced stage ovarian cancer or metastatic breast
cancer. Using an existing smartphone application, we will automatically track time spent on daily cancer
activities, augmented by participant-reported details on specific activities, well-being (daily), and quality of life
(baseline and end of study). We will estimate associations between objective time use and daily well-being,
explore variations in these associations by patient characteristics, develop a multidimensional scoring system
of time toxicity differentiating between episodic toxicity, travel toxicity, opportunity toxicity, and scheduling
toxicity, and measure the associations of these scores with patient reported psychosocial outcomes. Upon
completion we will have developed objective measures of daily time use by cancer activity and patient
characteristics (Aim 1), estimated associations with daily well-being and explored variations by patient
characteristics (Aim 2), and developed a multidimensional time toxicity scoring system (Aim 3). The proposed
research is innovative because time toxicity is a novel concept within cancer survivorship which we will capture
combining objective sensor data with self-report data. This study will have a significant impact because time
matters to patients and our measures of cancer care time burdens will facilitate future interventions to reduce
time toxicity.

Public health relevance
Project Narrative The time demands of cancer and its treatments are significant and take away from other activities important to individuals with cancer. Using automated sensor data, we will measure objective cancer-related time use over a 28-day period, augmented by self-reported specific cancer activities, well-being, and quality of life to develop a scoring system of cancer-related time burden among adults with advanced ovarian or metastatic breast cancer. The project will have a positive impact by creating measures of cancer-related objective time use and subjective burden, enabling us to develop and measure the efficacy of future interventions to reduce cancer time demands.